Identification and Validation of Biological Sub-phenotypes of Sepsis-induced Acute Kidney Injury: A Precision Medicine Approach to Improve Clinical Outcomes

PROJECT SUMMARY/ABSTRACT
Acute kidney injury (AKI) is the most common form of organ failure in sepsis and sepsis-induced AKI is
associated with prolonged hospitalization, need for acute dialysis, persistent AKI, and death. Despite this
public health impact, no effective pharmacotherapy exists for the treatment of sepsis -induced AKI. One
reason may be that heterogeneity is present within AKI, thereby concealing unique pathophysiologic processes
specific to certain AKI populations. The applicant is an early career investigator who has generated preliminary
data demonstrating that two novel AKI sub-phenotypes are present within the larger heterogeneous AKI clinical
population. Our group demonstrated that these AKI sub-phenotypes have differing risk for clinical outcomes
and response to vasopressin therapy, independent of traditional criteria to risk stratify AKI. We also identified a
3-variable model that included plasma markers of endothelial dysfunction and inflammation to identify the two
AKI sub-phenotypes. These findings were subsequently replicated by an independent research group. Through
this body of work, we have consistently shown in sepsis-induced AKI that these two AKI sub-phenotypes are
reproducible, prognostic and predictive. Important next steps for translating these findings to the bedside
include: 1) expanding the pool of candidate biomarkers to identify these or alternative AKI sub-phenotypes in
the emergency room (ER), an earlier and critical time to implement strategies to prevent or treat AKI; 2)
evaluating response of AKI sub-phenotypes to volume of intravenous fluids, a therapy given to almost all
patients with sepsis-induced AKI; and 3) probing whether the AKI sub-phenotypes different in terms of
pathophysiologic mechanisms. We will complete the proposed Aims in two ongoing NIH-funded studies, 1)
Crystalloid Liberal or Vasopressor Early Resuscitation in Sepsis (CLOVERS) and 2) Kidney Precision Medicine
Project (KPMP).
In Aim 1, we will identify sepsis-induced AKI sub-phenotypes using biospecimens collected in the ER and
determine associations with clinical outcomes in CLOVERS. We will apply two innovative approaches to
identify AKI sub-phenotypes (an unsupervised clustering and a previously developed 3-variable model).
In Aim 2, we will determine whether sepsis-induced AKI sub-phenotypes respond differently to a restrictive
fluid/early vasopressor versus a liberal fluid/late vasopressor resuscitation strategy.
In Aim 3, we will identify histological lesions from kidney biopsy tissue and urinary proteins associated with
sepsis-induced AKI sub-phenotypes in biospecimens collected during AKI in KPMP.
The outstanding qualifications of our team in the field of AKI, sepsis, molecular epidemiology, and
interventional clinical trials uniquely position us to align clinical care with underlying molecular mechanisms to
inform a ‘precision’ approach to the study and care of patients with sepsis-induced AKI.

Public health relevance
PROJECT NARRATIVE Acute kidney injury (AKI) is the most common form of organ failure in sepsis and sepsis-induced AKI is associated with prolonged hospitalization, need for renal replacement therapy, and death; however, no effective pharmacotherapy exists for the treatment of sepsis-induced AKI. We have shown the presence of two distinct AKI sub-phenotypes with different 1) clinical and molecular characteristics, 2) outcomes, 3) genetic risk and 4) response to therapeutics. This application will determine whether these or alternative AKI sub-phenotypes are present in the emergency room, whether AKI sub-phenotypes respond differently to volume of intravenous fluids, and whether differences in kidney histopathology and urinary proteomics exist between sepsis-induced AKI sub-phenotypes.